An Interpersonal Relationships Intervention for Improving Cardiovascular Health in Youth

PROJECT SUMMARY
Disparities in cardiovascular (CV) diseases by socioeconomic status (SES) and race/ethnicity are pronounced
in our society, and the processes that lead to these disparities begin in childhood. Previous intervention efforts
have targeted individual lifestyle changes in health behaviors, but with limited success in low SES, minority
youth. We propose a novel intervention to reduce CV risk in low SES, minority children (under 21 by NIH
guidelines) that focuses on social relationships – specifically mentoring – as a way to create bi-directional
benefits for CV health in youth. The rationale for this intervention is based both on work showing that receiving
social support has benefits for physical health, and on work demonstrating that helping others is associated
with better physical health. In this proposed intervention study, college students will serve as mentors to
elementary school students (8th graders). 250 college students and 250 Chicago Public School 8th graders will
be randomized to either serve as a mentor/mentee or to be in a control group. Students will participate in a
weekly mentoring intervention throughout one school year. Assessments will occur at 3 time points during the
school year. All mentors and mentees will come from low-income families and underrepresented minority
groups, thus allowing us to focus on improving CV health in an at-risk population that experiences a
disproportionate share of the CV burden in the U.S. The first aim of the project is to investigate whether
mentors can reduce CV risk (obesity; blood pressure; cholesterol; blood glucose) in low-income, minority youth
mentees relative to a control group of 8th graders. The second aim is to investigate whether serving as a
mentor can reduce CV risk in the college student mentors compared to a control group of college students.
The third aim is to understand how mentoring influences the intervention targets of psychosocial, health
behavior, and biological variables, and whether these variables mediate the impact of mentoring on CV health.
Drawing from the stress buffering model of social support, we propose that mentoring fosters the development
of strong social relationships that can scaffold behavioral changes and hence mitigate the effects that stress
has on inflammation and CV health via 2 pathways: psychophysiological and health behaviors. In the
psychophysiological pathway, mentoring creates more adaptive cognitive, emotional, and behavioral
responses to life stressors, which in turn mitigate responses of the sympathetic and neuroendocrine systems to
stress. Over time, this reduces inflammation and improves CV health. In the health behaviors pathway, the
scaffolding from mentoring relationships mitigates the associations of stress with detrimental health behaviors
that in turn are linked to both inflammation and CV health. Through this study, we take a social relationships-
oriented primary prevention approach to reducing health disparities by targeting CV risk factors that emerge
early in life and that predict clinical CV disease outcomes into adulthood and by focusing on low-income,
minority mentors and mentees who represent an at-risk, underserved, and disadvantaged group of youth.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE STATEMENT This project will implement a mentoring intervention pairing low-income minority college students as mentors to low-income minority elementary school students, and investigate the effects of mentoring on the cardiovascular health of both mentees and mentors. From a single intervention, we have the potential to create cardiovascular health benefits among both younger youth (mentees) and older youth (mentors) simultaneously through a novel approach that focuses on the beneficial influences that a social relationship between a mentor and mentee can have in helping to scaffold positive behavioral changes. This project takes a primary prevention approach by focusing on cardiovascular risk factors that emerge during childhood and as well, targets health disparities by focusing on an at-risk group of low-income, minority youth.